Cardiac CT: Advanced Architectures and Algorithms

DESCRIPTION (provided by applicant): Cardiovascular diseases are pervasive with high mortality and morbidity at tremendous social and healthcare costs. There are urgent needs for significantly higher fidelity cardiac CT with substantially lower radiation dose, which is currently not possible because of technical limitations. Although cardiac CT technology has improved significantly from 16 to 320 detector rows and from single to dual source, there remain technical challenges in terms of temporal resolution, spatial resolution, radiation dose, and so on. Based on an ideal academic-industrial partnership between Virginia Tech and the GE Global Research Center (GEGR), we are motivated to advance the state-of-the-art in cardiac CT dramatically and define the next generation cardiac CT system. The overall goal of this project is to develop novel cardiac CT architectures and the associated reconstruction algorithms, and define the next-generation cardiac CT system. The specific aims are to (1) design, analyze and compare novel cardiac CT architectures with novel sources and scanning trajectories;(2) develop analytic and iterative cardiac CT reconstruction algorithms for ROI-oriented scanning and dynamic imaging for the proposed cardiac CT architectures;and (3) evaluate and validate the proposed architectures and algorithms in theoretical studies, numerical simulations, phantom experiments and observer studies. On completion of this project, we will have singled out the most promising cardiac CT architecture and algorithms to achieve 16cm coverage, 50ms temporal resolution, 20lp/cm spatial resolution, 10HU noise level, and 5mSv effective dose simultaneously for the entire examination, with detailed specifications and performance evaluation, setting the stage for prototyping a next-generation cardiac CT system in a Phase-II project. This project will make a quantum leap in cardiac CT, in the sense that our proposed cardiac CT technology will enable significantly better diagnostic performance and bring major therapeutic benefits that affect 61.8 million Americans. PUBLIC HEALTH RELEVANCE: Cardiovascular diseases are pervasive with high mortality and morbidity at tremendous social and healthcare costs. Cardiac CT technology needs major improvements to capture a fast beating heart with better image clarity at lower radiation dose. The overall goal of this project is to develop the next generation cardiac CT architecture and algorithms for significantly superior diagnostic performance and therapeutic outcomes that affect 61.8 million Americans.

Public health relevance
Project Narrative Cardiovascular diseases are pervasive with high mortality and morbidity at tremendous social and healthcare costs. Cardiac CT technology needs major improvements to capture a fast beating heart with better image clarity at lower radiation dose. The overall goal of this project is to develop the next generation cardiac CT architecture and algorithms for significantly superior diagnostic performance and therapeutic outcomes that affect 61.8 million Americans.